Clinical Research Resources

This project number was established solely for the purpose of capturing the end of year cost of the Clinical Center Management Fund. A committee within NIH decided that the end of year report should use one Z01 number to report this amount.